Identification of novel MDR antimicrobials from insect-Streptomyces symbioses

Abstract
To combat the constant emergence of multidrug-resistant pathogens, the discovery of structurally novel natural
products with antimicrobial properties is a critical need. As part of the Wisconsin Antimicrobial Drug Discovery
and Development Center, we will address the urgent need for new antimicrobial drug leads by exploiting an
innovative source: Streptomyces symbionts of insects. In our preliminary work we have shown that these
Actinobacteria represent a rich and largely untapped source of novel antimicrobials with therapeutic potential.
For example, we have shown in vivo (murine) safety and efficacy against Gram-negative bacterial and fungal
human pathogens for several dozen lead molecules. In addition, we have confirmed antifungal efficacy and
safety in our FDA-enabling murine model for our drug lead Cyphomycin, a novel molecule we discovered from
an insect-Streptomyces. In our approach, we will also apply new genomic and metabolomic approaches, along
with ecologically-informed bioassays. Our research will help reinvigorate the antimicrobial discovery pipeline and
identify new MDR active drug leads.

Public health relevance
Narrative: Antibiotic resistant pathogens represent a major health issue. Here, we propose employing an innovative discovery platform to discover novel, effective, and safe antimicrobial drugs. Further, our approach will focus on Streptomyces symbiotic bacteria from insects, which represent a rich source of new antimicrobials stemming from their ecological role in mediating pathogen dynamics associated with their insect host.